Neural processing of communication sounds: acoustic features and semantic content

Project Summary
Acoustic communication is crucial for social interactions in many species, including humans.
Understanding the neural underpinnings that govern the production and processing of communication sounds is
paramount to advance the fields of auditory neuroscience and social behavior. Studies investigating speech and
sound processing in humans have mostly implemented non-invasive methods, leaving a gap in knowledge about
underlying neural mechanisms. My project bridges this gap by exploiting scientific advantages of echolocating
bats, mammals that produce and process a rich repertoire of acoustic signals, to investigate the circuits that
contribute to the discrimination of complex sounds that carry different meanings. Bats are social mammals with
well-developed audio-vocal systems and produce ultrasonic vocalizations for navigation and social
communication, providing a distinct opportunity to study the pathways, molecules and brain regions, which
enable complex sound processing. Aim 1 combines behavior and neurophysiology to investigate the specific
acoustic features of communication calls that are key to evoke behavioral responses and the neural systems
involved in sound discrimination. Aim 2 combines psychophysical, neurophysiological, and pharmacological
inactivation methods to study the midbrain-amygdala circuit's role in mediating discrimination of sounds that
show overlap in spectro-temporal features but carry different semantic content. Aim 3 investigates circuit
phenomena in a social context by combining neurophysiological recordings and targeted pharmacological
inactivation in freely interacting bats. The overarching hypothesis of this research program is that social-
emotional processing of auditory stimuli through a midbrain-amygdala circuit mediates the discrimination of
sounds that carry different meaning. The significance of this project resides in the extraordinary scientific
opportunities to bridge studies of auditory behaviors, single neuron recordings, circuit dissection and
computational modeling in a mammalian model. This work will contribute key new knowledge of natural sound
processing mechanisms in mammals that could inform a deeper understanding of human auditory
communication disorders. Johns Hopkins University offers an outstanding environment to conduct this project,
as it provides access to world class research facilities, seminars and workshops offered by the Center for Hearing
and Balance, the Center for Language and Speech Processing; along with an extraordinary network of mentors
and collaborators who will provide training and guidance to ensure the success of this project.

Public health relevance
Project Narrative Small changes in acoustic features of communication sounds can dramatically alter their meaning; for example, in human language, the words “bat” and “rat,” sound similar, yet they refer to two different animals. Furthermore, behavioral context aids sound discrimination, yet the neuronal pathways that mediate the effect of context on the discrimination of complex sounds with different semantic information remain difficult to study in human subjects, creating the crucial need for mammalian animal models that are auditory specialists. The proposed research, employing bats as model organisms, will investigate the mechanisms mediating auditory processing in the mammalian brain, and will contribute to knowledge that can help in the diagnosis and treatment of humans who suffer from communication disorders.